Leveraging Heath Information Technology to Improve Post-Discharge Management for Patients with Heart Failure

Project Summary
My long-term career goal is to become a clinician investigator, who uses health information technology (IT) to
improve cardiovascular outcomes among patients with social needs. The research goal of this application is to
use health IT to reduce preventable readmissions for heart failure (HF) among patients with low health literacy
with the incorporation of behavioral science and usability testing. Social determinants of health (SDH) account
for 80% of health outcomes, and social needs are associated with poor health outcomes, including 30-day
readmissions. Addressing individuals’ social needs has been associated with improved clinical outcomes, but
may take a prolonged time to effectively reduce 30-day readmissions. Health literacy, which measures a
patient’s ability to find, understand, and use information and services to inform health-related decisions and
actions for themselves and others, is associated with patients’ health outcomes. Low health literacy is common
among patients with HF, and leads to poor management of HF. Extant interventions, such as patient
navigators and handouts, have been utilized successfully to improve medical care for patients with low health
literacy, but they are episodic and resource-intensive. The use of health IT tools, such as a personalized,
automated text-message-based application, can be utilized for post-hospitalization care. Our preliminary study
indicates that patients with HF who use this application had reduced 30-day readmissions, compared to
patients with HF who did not use the application. However, the number of patients with HF using the
application has been limited, due to low uptake and high attrition rate. The overall objective of the proposed
research project is to incorporate nudges, and address barriers to improve patients’ use of the application, and
conduct a pilot randomized controlled trial (RCT) to evaluate the application’s use in reducing 30-day
readmissions. We will conduct qualitative work to gain insights into how to adapt an extant text messaging
intervention to improve its use among patients with low health literacy (Aim 1), conduct usability testing and
iterative revision of the application (Aim 2), and conduct a pilot RCT to evaluate the acceptability, feasibility,
and preliminary efficacy of using behavioral interventions to increase the application use for patients with HF
post-discharge (Aim 3). The training from this mentored career development award will provide skills in four
domains: 1) behavioral science; 2) implementation science; 3) health literacy; and 4) RCT design and conduct.
The proposed research activities, and the training and mentoring plans will provide the foundation for my
career as an independent clinician investigator.

Public health relevance
Project Summary The research goal of this application is to use health IT to reduce preventable readmissions for heart failure (HF) among patients with low health literacy, through a text-based messaging application. We will conduct qualitative work to gain insights into how to adapt an extant text messaging intervention to improve its use among patients with low health literacy, conduct usability testing and iterative revision of the application, and conduct a pilot randomized controlled trial (RCT) to evaluate the acceptability, feasibility, and preliminary efficacy of using behavioral interventions to increase the application use for patients with heart failure post- discharge. The training from this mentored career development award will provide skills in behavioral science, implementation science, health literacy, and RCT design and conduct, to provide the foundation for my career as an independent clinician investigator.